Mechanisms of Cell Adhesion Molecule Function in Retinal Development

ABSTRACT
Neural circuit formation requires a series of highly diverse and specific cell-cell recognition steps, many mediated by cell
adhesion molecules (CAMs). Indeed, mutations that disrupt CAMs or their regulation are associated with circuit level
neurodevelopmental disorders from dyslexia to schizophrenia. Our model is the mouse retina, an extension of the
central nervous system where ~100 types of neurons organize into dedicated circuits that encode the features of the
visual world. We focus here on the gamma-protocadherins (γ-Pcdhs), 22 CAMs expressed from a single gene cluster that
generate many thousands of distinct homophilic recognition complexes. The γ-Pcdhs are critical regulators of neuronal
self-avoidance in starburst amacrine cells (SACs), and cell survival and in many other types of neurons in the retina. The
mechanisms through which the γ-Pcdhs serve these functions are unknown, as is the importance of γ-Pcdh isoform
diversity. We used a CRISPR/Cas9 approach to generate an unbiased allelic series of mouse mutants with between 1 and
21 intact γ-Pcdh isoforms. From these, we learned that one isoform, γC4, is essential for neuronal survival, suggesting
that this isoform functions differently from the other 21. We propose to define the mechanisms of self-avoidance and
neuronal survival, and to use our allelic series to determine the level of isoform diversity required for normal neural
circuit formation. Our central hypotheses are that: 1) a high level of γ-Pcdh isoform diversity enables neurons to
distinguish between “self” and “non-self” to mediate self-avoidance while permitting interaction with neighboring
neurons through mechanisms common to all isoforms; and 2) neuronal survival, in contrast, requires interactions
specific to the γC4 isoform. In Specific Aim 1, we will use a strategic subset of our reduced-diversity mutants to
determine the extent of isoform diversity required for self/non-self discrimination in SACs, neurons essential for the
motion detection circuit in the retina. We will analyze this circuit at two levels: A) morphology of contacts between
SACs, and B) the electrophysiological function of direction-selective retinal ganglion cells, the downstream neurons in
the circuit. In Specific Aim 2, we will define the molecular mechanisms of self-avoidance using in vivo gene delivery to
manipulate candidate pathways and map essential domains. In Specific Aim 3 we will uncover the mechanisms through
which γC4 promotes neuronal survival. We will use retinal electroporation to map critical protein domains,
complemented by a discovery-based proteomics approach to find isoform-specific protein interactions for γC4. These
studies will allow us to better understand how the γ-Pcdhs contribute to cell-cell recognition and neural circuit
formation in the retina and provide insight into processes disrupted by neurodevelopmental disorders.

Public health relevance
PROJECT NARRATIVE The proposed research will address the biology of neural circuit formation in the retina and is relevant to public health for understanding both the biology of vision and the basic processes through which the nervous system organizes itself during development. Further, it will identify functional mechanisms for a family of molecules that are essential for normal neural development and that are mutated or dysregulated in disorders from dyslexia to schizophrenia. Identifying these mechanisms is a crucial step towards understanding these disorders and developing therapeutic strategies to treat them.